Evaluating the adoption, implementation, and maintenance of a cervical precancer treatment in El Salvador

PROJECT ABSTRACT
Much of what we know about how and why evidence-based interventions (EBIs) are adopted, spread, and
sustained comes from high-income countries; lack of research produced in low- and middle-income countries
(LMICs) limits the generalizability of current data. To bridge this gap, it is critical to understand how features
commonly found in LMICs shape implementation outcomes. The recent World Health Organization's (WHO)
call to eliminate cervical cancer (CC) provides a timely opportunity to gather such evidence, as it has generated
significant momentum to introduce prevention-focused EBIs to regions with moderate and high disease burden.
Vaccination, screening, and triage have received some attention, but there is very limited data on the uptake,
implementation, and sustainability of cervical precancer treatments. Thermal ablation (TA) is a safe and effective
treatment that has rapidly gained popularity as a point-of-care alternative to gas-based cryotherapy, the most
widely used cervical precancer treatment in LMICs. TA was added to WHO recommendations in 2019, and
several LMICs have included it in their guidelines, including El Salvador. US-based and international agencies
have made TA devices available to at least 14 LMICs, and there is great interest in expanding this practice. El
Salvador, which recently included TA in its cancer control guidelines, received a donation of 70 TA units as part
of this trend and began to roll out the treatment in October 2022. As an early adopter, El Salvador provides a
unique opportunity to investigate the integration of a new EBI in the national health system, assess current
implementation outcomes, and identify leverage points that can promote sustainability. We have assembled a
multi-disciplinary team of US and El Salvador-based researchers with extensive experience in the country to
assess the early implementation of TA in the cervical cancer prevention program and generate evidence for
future scale-up and sustainment. The research will be completed through the following: Specific Aim 1) Conduct
an observational mixed-method post-implementation evaluation of the early implementation of TA in El Salvador
guided by the Expanded RE-AIM framework; Sub-Specific Aim 1.1) Conduct a micro-costing analysis to
compare delivery costs of cryotherapy vs. TA as treatments for cervical precancer; and Specific Aim 2) Using
an implementation mapping approach, identify successes and gaps in the implementation strategies used to
introduce TA in El Salvador. Findings will be instrumental in developing an R01 study to develop and test
implementation strategies of cervical cancer prevention EBIs in El Salvador and other LMICs.

Public health relevance
PROJECT NARRATIVE Much of what we know about how and why evidence-based interventions (EBIs) are adopted and sustained comes from high-income countries; lack of research produced in low- and middle-income countries (LMICs) limits the generalizability of current data. The recent World Health Organization's call to eliminate cervical cancer provides a timely opportunity to gather such evidence, as it has generated significant momentum to introduce prevention-focused EBIs to regions with moderate and high disease burden. The purpose of this research is to evaluate the early implementation of an innovative cervical precancer treatment in El Salvador, and to identify successes and gaps in current implementation strategies in order to ensure its long-term sustainability.